Sex, HIV, and Lung Health Across the Life Course: The Uganda Lung Health Study

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is the leading respiratory cause of death worldwide, and by
2050, sub-Saharan Africa (sSA) will bear the greatest COPD burden despite the lowest smoking rates in the
world. HIV is an important yet underappreciated driver of COPD risk that leads to more aggressive and fatal
disease, particularly among women, for reasons that have not been fully elucidated. The intersection between
HIV, sex, and COPD risk is particularly important in sSA, where most of the global population with HIV lives, over
half of whom are women and girls. Consequently, two major public health priorities include understanding the
mechanisms of COPD in women with HIV in sSA and developing methods to identify at-risk individuals and
interventions to prevent or reduce its impact on their health. To accomplish these priorities and respond to the
growing epidemic, data are needed in this population prior to the development of COPD at potentially
intervenable timepoints. Unfortunately, longitudinal lung health data prior to COPD and mechanistic data to
elucidate pathobiology and identify at-risk populations are rarely available in sSA. This proposal is led by experts
in adult and adolescent lung disease epidemiology, quantitative chest imaging analytics, proteomic biomarker
science, and risk prediction scores in sSA. In this proposal, we will build upon our preliminary data that suggest
that women with HIV have particularly elevated risk of HIV-associated lung disease by establishing the Uganda
Lung Health Study, a cohort of 800 adolescents and adults that is evenly balanced by sex and HIV and spans
the entire adult lifespan from 16 to 90 years of age. We will follow these 800 individuals with three annual study
visits where we will collect post-bronchodilator spirometry, study questionnaires, blood samples, and non-
contrast chest CT imaging to accomplish the following aims: Aim 1: To identify trajectories of lung
dysfunction across the lifespan and their key risk factors in adolescent girls and women with HIV in
Uganda. We will estimate lung function trajectories via group-based trajectory modeling using 2,400 spirometry
measures from 16 to 90 years old. Our secondary outcomes are categorical lung dysfunction and parenchymal
lung disease. Our primary predictors are HIV and sex, and we will also consider demographic, environmental,
clinical, and HIV-specific factors. We will identify key risk factors through clinical prediction scores and clinical
prediction algorithms. Aim 2: To identify candidate biological pathways that predict lung dysfunction
among adolescent girls and women with HIV in Uganda. We will assess biological pathways using proteomic
signatures, and will compare signatures predictive of abnormal lung function trajectory and parenchymal lung
disease by sex and HIV serostatus, with the goal of motivating future work to develop HIV- and/or sex-specific
interventions. Our work will provide insights into potentially targetable risks and biological pathways in Uganda
and will guide mechanistic and intervention studies to preserve lung health among PWH, which is directly
responsive to NHLBI, Office of AIDS Research, and Office of Research on Women’s Health research priorities.

Public health relevance
PROJECT NARRATIVE The widespread provision of life-saving antiretroviral therapy has transformed the HIV epidemic for many into a chronic, survivable condition, so to sustain the considerable investments made by the US government and in- country partners and ensure the well-being of people living with HIV, the next phase of the HIV response must also focus on addressing chronic, non-AIDS health priorities – such as HIV-associated COPD – for the nearly 26 million people living with HIV in sub-Saharan Africa. The current project directly addresses this goal by 1) defining regionally relevant risk factors for lung dysfunction across the lifespan among adolescents and adults with HIV and 2) identifying unique biological pathways associated with HIV-associated lung dysfunction. In doing so, the project will respond to numerous gaps in our understanding of lung health among adolescents and adults with HIV and lay the groundwork for interventions to prevent lung disease and reduce disease progression among at risk populations.